Microbial Influence on Mucosal Homeostasis

SUMMARY/ABSTRACT
The gastrointestinal mucosa functions as an interface between the luminal contents and the underlying tissue
compartments, and is thus vital in maintaining mucosal and systemic homeostasis. The gut lumen houses a
numerically vast and taxonomically diverse prokaryotic microbiota. In health, the mucosa and microbiota thrive
in a mutually beneficial symbiotic arrangement. Both host and microbe have evolved a complex system of
mutual perception, response and reaction. These events are mediated in part by the ability of the intestinal
epithelia to respond to specific members of the microbiota by the production of reactive oxygen species (ROS),
that serve to activate multiple cellular pathways involved in the maintenance of gut homeostasis. This proposal
will employ in vivo systems including extensive use of germ-free mice, or mice gnotobiotically colonized with
known ROS inducing bacteria. Additionally, taxonomic analysis of microbiota in neonatal mice will be used to
identify other bacteria with functional effects on the gut mucosa. The proposal will study microbial influences on
known and novel signaling pathway, and characterize the regulatory effects on gut survival, differentiation and
proliferation. Our overall objectives are to define the participants, events, and processes involved in
host microbial contact and how this interaction influences intestinal homeostasis, development and
restitution. ROS and redox-stimulated pathways likely represent a conserved mechanism by which the host
interacts with its commensal microbiota, and thus presents an attractive target for therapeutic manipulation.

Public health relevance
PROJECT NARRATIVE The mammalian gut microbiota is a complex and vast microbial community that influences a wide range of normal physiological functions in the intestine and in the body as a whole, and when quantitatively or qualitatively disturbed, can contribute to a wide and increasingly recognized range of inflammatory, immune, infectious and metabolic diseases. This proposal will use state of the art bioexclusion technology to maintain mice with highly specific and controlled microbiota and evaluate roles of specific bacteria on normal and pathological processes. This work aims to identify novel beneficial bacteria and mechanistically define how these bacteria can contribute to health.